A systems analysis of drug tolerance in Mycobacterium tuberculosis

PROPOSAL SUMMARY
This project will address the critical need for accelerated development of multidrug regimen to achieve fast and
complete clearance of Mycobacterium tuberculosis (Mtb), thereby lowering the likelihood for the emergence of
antimicrobial resistance. Mtb dynamically adapts to extra- and intracellular host environments by adopting
heterogeneous physiologic states, with varied susceptibility profiles to frontline antitubercular drugs. In the first
four years of the R01, we have made progress towards dissecting this capability of Mtb by developing
technologies to (i) uncover regulatory mechanisms that drive the pathogen into dormant states in host-simulated
environments (controlled bioreactors) and directly within host cells (Path-seq), (ii) sort and characterize at single
cell resolution translationally-dormant persister-like subpopulations within isogenic cultures (PerSort), (iii)
uncover and characterize context-specific vulnerabilities within regulatory and metabolic networks (EGRIN2 and
PRIME), and (iv) rationally formulate novel synergistic drug combinations (DRonA and MLSynergy). Using these
capabilities and their applications reported across sixteen publications, we discovered that heterogeneous drug
tolerant subpopulations co-exist within an isogenic culture of Mtb, even in the absence of drug treatment.
Furthermore, we discovered that stressful environments and treatments activate additional drug tolerance
networks, which may potentiate the emergence of resistance. Based on these findings, we hypothesize that we
can achieve fast and complete clearance of Mtb infection with a combination of drugs that target vulnerabilities
across heterogeneous drug tolerant subpopulations that co-exist in varied combinations and proportions
depending on host- and treatment-contexts. To test this hypothesis, we will mechanistically characterize how the
heterogeneous population structure of Mtb changes dynamically in response to host-relevant environmental cues
and drug treatments. We will then uncover and characterize vulnerabilities within regulatory and metabolic
networks that support and drive transitions to drug tolerant states. Using machine-learning techniques, we will
predict and validate synergistic drug combinations targeting multiple vulnerabilities to cripple heterogeneous
environment- and drug-induced states of Mtb. By performing time kill curves, we will investigate whether
validated combinatorial interventions accomplish complete and faster clearance of heterogeneous Mtb
subpopulations in diverse contexts. Altogether, the proposed activities will identify novel drug targets, and novel
drug combinations for fast and complete clearance of a heterogeneous Mtb population. Given that phenotypic
heterogeneity as a means for tolerating and resisting drugs is a universal phenomenon, the systems biology
framework developed in this project will be generalizable to the discovery of effective multidrug regimen for
diverse infectious diseases and even cancers.

Public health relevance
PROJECT NARRATIVE Infection with Mycobacterium tuberculosis (Mtb) caused 10 million new cases of active tuberculosis (TB) disease and 1.5 million deaths, in 2019, making TB the leading cause of death in the world by a single infectious agent. The long treatment duration, spectrum of clinical outcomes, high disease relapse, and emergence of drug resistance are all complications of TB treatment attributable to the intrinsic heterogeneity of the disease. Strategies developed in this project will accelerate development of multidrug regimen that will be efficacious against heterogeneous drug tolerant subpopulations of Mtb, achieving faster clearance and lowering the likelihood for evolution of resistance.